In vivo evaluation of a CT-compatible retractor for image guided trans-oral surgery

PROJECT SUMMARY
Cancers of the head and neck (oral cavity, pharynx, and larynx) are the 5th most common cancers worldwide.
Trans-oral surgical approaches such as trans-oral robotic surgery (TORS) and trans-oral laser microsurgery
(TLM) are effective, reducing complications and long-term treatment morbidity. One of the drawbacks of the
trans-oral approach is the difficulty in intraoperatively assessing tumor extent and locating critical vascular
structures, resulting in positive margins and risks of vascular complications. Image guidance and surgical
navigation play a significant role in sinus, skull base, and neurosurgery, demonstrating improvement in the safety
and efficacy of these procedures. There may be advantages to applying this technology to trans-oral surgery
(TOS) for improved assessment of tumor depth and avoidance of vascular structures. Image guidance is
currently not feasible for trans-oral surgery. The main reason is the significant intraoperative tissue deformation
that occurs with the introduction of retractors needed to provide surgical access. This intraoperative deformation
limits the ability to accurately register preoperative imaging to the intra-operative state. With the availability of
intra-operative CT and MRI imaging at Dartmouth’s unique Center for Surgical Innovation, intra-operative
imaging is feasible. However, current metallic instrumentation required for exposure and airway management
during trans-oral surgery creates significant artifact on CT imaging. As part of an on-going NIH-funded R21
program (1R21CA246158-01A1), we have developed a novel 3D printed polymer retractor that enables us to
acquire artifact free images of cadaver head during trans-oral surgery procedures and a surgical navigation
framework to enable image-guided trans-oral robotic surgery. The work in this R21 is being performed on
benchtop models and cadaver heads. Here in this R03, we are first proposing to prepare the retractor for in vivo
deployment by evaluating the impact of sterilization on mechanical properties of the retractor and confirming
system stability over the time-period of a typical TORS procedure. Secondly, we aim to deploy this retractor in a
series of intraoperative trans-oral surgery procedures and compare the surgical working volume and function to
that of standard metal retractor systems. The overarching goal of our efforts is to improve the safety and efficacy
of trans-oral surgery and enable surgeons to perform surgery on more complex cases through the use of surgical
navigation. Performing this in vivo evaluation in parallel with our R21 efforts to develop an image-guidance
framework will accelerate our transition to in vivo evaluation of image-guided TORS. By the end of this program
we expect to be prepared to evaluate a fully integrated surgical guidance system for use in trans-oral robotic
surgery. Follow on in vivo human studies will be proposed to evaluate the efficacy of this framework in a clinical
population of patients undergoing TORS.

Public health relevance
PROJECT NARRATIVE The overarching aims of this program are to reduce complications and improve outcomes for minimally invasive robot-assisted throat cancer surgery by enhancing the surgeon’s ability to assess tumor extent and localize vascular and other critical anatomic structures. We aim to examine the feasibility of image guidance technology by deploying a CT compatible retractor in a cohort of patients undergoing trans-oral surgery (TOS) and to demonstrate the efficacy and equivalence of our polymer retractor to that of standard of care metal retractor systems.